Learnings in Diabetes Prevention from an Integrated Delivery System

DESCRIPTION (provided by applicant): Project Summary / Abstract Kaiser Permanente Northern California (KPNC) and its Division of Research (DOR) propose a set of three evaluations of KPNC system-level efforts to prevent development of diabetes in high-risk members. One or more of these studies would be well-suited for pooling with data from other systems in this research network on similar interventions. The applicant research team is highly experienced in working with KPNC clinical and operational leaders to evaluate natural experiments in diabetes care, including recent evaluations as part of the CDC/NIDDK-sponsored TRIAD study. We believe this is an is an opportune moment to examine whether the population approaches that have been effective for patients with diabetes can be adapted to support high-risk pre-diabetic patients to modify lifestyles and prevent progression to diabetes. The primary evaluation is of a KP - employer partnership that has adapted its worksite wellness program to risk stratify all employees using electronic health record (EHR) data and to use intensive outreach, incentives, and coaching (web, telephone, or in-person) to support lifestyle change in high-risk employees. Intervention and control employer sites will be selected in consultation with CalPERS, a large benefits management group representing multiple employers. We expect to identify approximately 750 high-risk employees at each site. Impact will be assessed using both EHR and patient surveys (via mail, phone, or internet at baseline and 12 months) to measure changes in body mass index (BMI), physical activity, blood pressure and lipid levels. The first ancillary study evaluates a telephonic wellness coaching program established in January 2010. It is intended to be part of a portfolio of coaching support that also includes online and in-person services. It is operated by KPNC's Regional Health Education Department (RHE), and will target as many as 10,000 high risk persons per year when fully implemented. We will work with RHE to evaluate program impact among high risk members identified either from EHR or health risk appraisal data, or from a combination. Surveys at baseline and 12 months will again measure changes in BMI, physical activity, blood pressure and lipids. We will also assess readiness to change, preferences for type of coaching, and correlates of these preferences. A second ancillary study examines a regionwide program implemented in 2006 that aims to ensure postpartum screening for diabetes, using a 75-gram oral glucose tolerance test, in all women with gestational diabetes mellitus (GDM). The program conducts outreach to those who prove to have pre-diabetes at testing. The program will be evaluated by examining changes in population incidence (over 5 years postpartum) in cohorts of all women with GDM from 2001-05 vs 2006-2010 (n=12,000 in each cohort). Incidence will be divided into less severe (often screen-detected) and more severe (with A1c >8% or requiring two medications). We hypothesize that the program will lead to decreases in more severe diabetes but to increases in milder disease. We also list a number of natural experiments in diabetes care that we would be able to evaluate.

Public health relevance
Project Narrative Understanding how health care systems can organize to prevent diabetes mellitus is a relatively new area of interest among these systems. Researchers at Kaiser Permanente Northern California's Division of Research are proposing to collaborate with the CDC and with researchers from other health systems to study a variety of health system policy approaches to preventing diabetes mellitus among the 3.1 million members of KPNC. We have proposed evaluation studies of a health plan employer partnership that identifies employees at high risk for diabetes on intervenes using outreach and communication, feedback, incentives, and health coaching to change behaviors and reduce risk; a broader evaluation of a new telephone health coaching program that will ultimately be available to all adult members; and the Regional Perinatal Service Center's region-wide program for reducing risk among women who have had gestational diabetes mellitus. We hope that one or more of these studies can be replicated within other health systems and results pooled and shared. __SpecificAimsTextDelimiter__ Specific Aims We propose to conduct 3 evaluations of distinct system-originated efforts to prevent development of diabetes mellitus in high-risk member subpopulations. Each takes advantage of the system-wide EHR to identify a high- risk subpopulation. Each is an effectiveness study, evaluating outcomes for the entire target population, not for subsets of patients who choose to participate. Two studies compare groups of similar patients not invited or targeted for the intervention. The third is a population-wide evaluation of a system-wide implementation of a comprehensive new program for women with GDM. Here the only comparison is with prior performance and outcomes. Two of the three studies will involve brief surveys of patients to capture endpoints not routinely available from the EHR, including changes in levels of physical activity and dietary intake. We will: 1) Compare longitudinal differences in risk factor trajectories between employees at high risk for developing diabetes of a CalPERS employer that implements a multi-factorial worksite-based, Diabetes Risk program and similar high risk employees of a similar CalPERS employer that does not implement the program, testing three sets of hypotheses: a. Average increases in self-reported physical activity, improvements in food intake patterns, and decreases in body mass index will be greater for high-risk employees at the intervention site than for those at the comparison employer site over the one year following program implementation. b. Non-high risk employees of the intervention site will access KPNC on-line coaching programs more frequently than similar employees at the control site during the year following program implementation. c. At the intervention site, high risk employees who participate in coaching activities (online or telephonic) will demonstrate greater improvements in physical activity, dietary intake and BMI, and lower reported absenteeism than those who do not one year after program implementation. 2) Evaluate the effectiveness and efficacy of KPNC Regional Health Education (RHE) Department's new telephonic health coaching program when offered to adult member subpopulations at high risk for developing diabetes mellitus. Active recruitment will attempt to enroll a group of these patients to telephonic coaching or to alternative services (online coaching or face-to-face classes), depending on their preference. We will test the following hypotheses: a. Among patients at high risk for diabetes who indicate a readiness to change, those who are actively recruited to participate in a telephonic health coaching program (or alternative services) will demonstrate greater increases in self-reported physical activity, improvement in food intake patterns, and decreases in body mass index 12 months later, compared to similar patients not recruited. b. Among high-risk patients who indicate that they are not ready to change diabetes risk behaviors, those invited to participate in a telephonic health coaching program (or alternative services) will not participate at high rates and will not demonstrate significant improvements in physical activity, food intake patterns, or BMI compared to similar patients not invited to participate. c. Among the patients who are invited, those who accept the invitation and participate in the program will exhibit greater improvements in physical activity, food intake, and BMI. d. Members who select telephonic coaching will differ in terms of demographic and clinical characteristics from members who select online coaching or face-to-face services. 3) We will evaluate the population impact on patterns of incidence of Type 2 diabetes of a fully-implemented nurse referral program for women who have a pregnancy with GDM. This program has achieved a dramatic increase in postpartum screening for diabetes mellitus using the 75-gm OGTT. We hypothesize that: a. Cumulative incidence of "more severe" Type 2 diabetes characterized by either a Hb A1c value >8% or use of 2 or more oral medications at 4-years postpartum will be lower for the cohort of women who delivered in 2006 or later than for those women who delivered between 2002 and 2005. b. Cumulative incidence of less severe diabetes mellitus and of screen-detected diabetes mellitus will be greater for the cohort of women who delivered in 2006 or later than for those women who delivered between 2002 and 2005. c. Average BMI at 4 years postpartum will be lower for the cohort of women who delivered in 2006 or later than for those women who delivered between 2002 and 2005.